Advancing Craniosynostosis Treatment (ACT) Rare Diseases Consortium Pilot/Feasibility Governance Core

ABSTRACT: PILOT / FEASIBILITY GOVERNANCE CORE
The Advancing Craniosynostosis Treatment (ACT) Rare Diseases Consortium will advance high impact ideas
through the Pilot/Feasibility Governance Core, focused on a mission to improve care for patients and families
affected by syndromic craniosynostosis (CS). In the Pilot/Feasibility Governance Core (hereafter Pilot Core),
we will leverage the expertise, infrastructure, and resources of the Advancing Craniosynostosis Treatment
(ACT) Rare Diseases Consortium to catalyze research and collaboration in the craniofacial clinical and
research communities. Chiefly, the Pilot Core will identify and overcome key barriers that impede clinical
translation through three main aims: 1) Establish clinical priorities of syndromic CS, where the Pilot Core will
partner directly with patients, advocacy groups, foundations, and clinicians to establish consensus on greatest
shared clinical needs; 2) Construct the mechanism to recruit and fund projects aligned with clinical priorities,
where the Pilot core will recruit and prioritize pre-clinical and clinical pilot projects to supply with ACT expertise
and resources; 3) vet pilot projects under final consideration for compliance with NIH human subjects, data
sharing and other policies, and 4) Develop clinical trial readiness to move projects toward clinical translation,
where the Pilot Core will leverage insights from natural history and clinical outcomes studies to catalyze the
development of novel diagnostics and treatments for syndromic CS. The expected deliverable of this
Pilot/Feasibility Governance Core is to launch and accelerate pilot clinical projects towards clinical trial
development in subsequent RDCRN or other organizational mechanisms, and ultimately improve the
diagnosis, management, and treatment of syndromic CS.